CREATE Administrative Core

Project Summary. The Administrative Core for the Center for Responsible and Equitable AI-Based
Technology Evolution (CREATE) will build capacity, enhance innovation, and disseminate information to impact
public mental health by fostering an environment of collaboration and information sharing around responsible,
safe, and ethical use of large language models (LLMs) to support and extend use of evidence-based
psychotherapies (EBPs). The Administrative Core will serve CREATE by ensuring efficiency and research
synergy and by providing oversight and evaluation. We will develop a centralized home for center operations,
provide administrative and scientific leadership, and provide accessible communication platforms to
disseminate knowledge and resources. Dr. Shannon Wiltsey Stirman and Johannes Eichstaedt (MPI), the
Co-Directors of CREATE, will lead the Administrative Core. They bring experience in administrative and
scientific leadership, extensive professional networks, and partnerships with public mental health systems.
They have a record of mentorship in mental health intervention and implementation research, and
computational psychology. Together, they will oversee the organizational structures and processes that foster
collaboration and knowledge sharing across the multidisciplinary Center and to the broader field. Dr. Eric Kuhn
will oversee CREATE’s pilot program and coordinate mentoring activities, and Dr. Katherine Dondanville will
lead stakeholder engagement efforts. CREATE will benefit from the substantial and comprehensive resources
provided by Stanford University, including institutes and initiatives that support responsible and ethical use of
Artificial Intelligence, community engagement, digital health and mental health technology, and career
development and grantwriting. Our Center will serve as a national resource as we develop and refine methods
to safely and ethically develop and deploy Generative AI-based interventions (Mental Health AI-Generated
Interactive Conversational [MAGIC] tools) that support evidence-based PTSD treatment. The Administrative
Core will provide a range of activities including a pilot funding program, virtual workshops, grand rounds, and
expert consultation along with a repository of resources to disseminate information and support efforts in the
field to conduct development, research and implementation activities. We will foster a climate that inspires
innovation and collaboration while overseeing progress and providing quality control for our projects and
products. We will engage broad audiences through dissemination efforts such as scientific publications and
conference presentations, a repository of resources, and traditional and social media. Our interactive, public
domain, online portals will be essential tools for our researchers and partners to facilitate Open Science data
and resource sharing.

Public health relevance
The Center for Responsible and Effective AI Technology Enhancement (CREATE) of Treatments for PTSD Methods Core (MC) will make important contributions to support the use of effective treatments for PTSD using Large Language Models (LLMs). The overarching goal of the Methods Core is to serve the Center through Development and refinement of LLM-based tools that are designed to integrate into routine treatment settings and testing their effectiveness and readiness for deployment. To support this work across center research projects our team will involve people who will ultimately be using these tools in every stage of the design process, and evaluate the Safety, Privacy, Fit, Effectiveness, Engagement and Readiness for implementation of each tool